Cross-Training Core (ROBIN-NEST)

PROJECT SUMMARY
Education and training in the radiation medicine sciences are frequently compartmentalized along specific well-
worn paths with only superficial attention given to complementary disciplines. The mission of the
Harvard/UCSF ROBIN-Next generation Education and Scientific Training (NEST) is to organize and
support integrated educational, research and professional development initiatives that operate across
disciplines and training stages and serve as a model environment for the future radiation sciences workforce.
The ROBIN-NEST will disrupt the traditional training paradigm by creating and supporting a novel educational
and knowledge-sharing network that drives training, individual engagement and networking. The
Harvard/UCSF ROBIN-NEST will advance the following aims: 1) develop didactic materials with a new
learning platform for inter-disciplinary learning, 2) integrate knowledge-sharing across disciplines in the ROBIN
Network, and 3) advance professional development of the next generation of leaders in radiation medicine.
Through multidisciplinary educational partnerships the ROBIN-NEST will engage a wide and diverse network
of learners and educators including outreach to local schools through established, highly subscribed NIH-
funded programs. In all educational, training, and professional development activities, attention will be given
explicitly and implicitly to principles of diversity, equity and inclusion. The long-term objective of the ROBIN-
NEST is to establish and grow a new and unique cross-training paradigm. The ROBIN-NEST will cultivate a
new generation of scientists, ready to break down traditional barriers. We anticipate that this model will inspire
an enduring legacy of inter-disciplinary innovation beyond the ROBIN Network to bring impactful ideas to the
aid of the increasing population of patients and families seeking hope.